Application of plasma lipidomics to identify novel biomarkers of muscle and hepatic adiposity in population-based cohorts of older Black Caribbeans, Black Americans, and White Americans

ABSTRACT: Physical disability is common in U.S. older adults, with a higher prevalence in Black vs. White
Americans. Physical functioning declines with aging due to biomechanical and biochemical effects. Skeletal
muscle and the liver are highly active metabolic organs contributing to biochemical effects involved in multiple
physiologic processes. However, with aging, excess fat accumulates ectopically in and around muscle and the
liver, impairing normal functioning and causing negative metabolic consequences. In fact, skeletal muscle and
the liver share common pathophysiological mechanisms, e.g., insulin resistance and chronic inflammation, that
predict physical disability. Individuals of African ancestry have more muscle adiposity, but paradoxically, less
liver adiposity than White Americans. A better understanding of the underlying biology of muscle and liver adi-
posity in Black vs. White older adults could potentially explain health disparities. Lipidomics is a promising
method to better understand metabolic mechanisms underlying muscle and liver adiposity since it directly
measures lipids left behind from cellular processes that have shown to have extensive biological relevance.
The Principal Investigator, Dr. Marron, previously found several triglycerides were higher and several were
lower in older adults with high vs. low walking ability, where the direction in associations directly depended on
degree of fatty acid saturation. These findings led to this project, to investigate lipid pathways associated with
muscle and liver adiposity, since ectopic fat depots are likely major drivers of functional capacity with aging and
both muscle and liver share common pathophysiologic processes that predict disability. Thus, Dr. Marron pro-
poses to apply lipidomics to measure >1000 plasma lipids and use existing computed tomography of skeletal
muscle and the liver in a subset ages 50+ from the Tobago Study, a Black Caribbean cohort and the Coronary
Artery Risk Development in Young Adults (CARDIA) study, a Black and White American cohort. This proposal
will: 1) characterize, for the first time, differences in muscle and liver composition in Black Caribbeans, Black
Americans, and White Americans; 2) compare associations between lipids and muscle and liver adiposity in
Black Caribbeans, Black Americans, and White Americans and assess if differences are driven by ancestry
admixture or environment/behavior; and 3) develop and validate a metabolite composite score indicative of
muscle and liver health. The career development award will provide protected time for Dr. Marron to cultivate
her emerging research program and initiate a path towards independence. The proposal has been designed to
1) gain didactic training in biochemistry, lipid metabolism, and body composition by race/ethnicity; 2) leverage
cutting-edge techniques, i.e., untargeted lipidomics with a novel isotope dilution approach and computed to-
mography, to expand existing knowledge of underlying pathogenic mechanisms of muscle and liver adiposity;
and 3) enhance mentorship and grantsmanship to obtain funding to reach a long-term goal of elucidating novel
intervention targets to preserve muscle and liver health and physical functioning with aging.

Public health relevance
PUBLIC HEALTH RELEVANCE: Excess fat can accumulate ectopically in the liver and muscle, has negative metabolic consequences, and differentially impacts specific racial/ethnic subgroups of older adults. This project seeks to measure plasma lipidomics (>1000 lipids) and use existing computed tomography scans of the abdo- men to provide a better understanding of the biology of muscle and liver adiposity among Black Caribbeans, Black Americans, and White Americans. This study will provide evidence of lipid pathways associated with muscle and liver adiposity and differences in these pathways among individuals of varying degrees of African admixture to help elucidate important racial disparities in health outcomes.